Care of the elder hospitalized patient: the role of the hospitalists

DESCRIPTION (provided by applicant): This represents a competitive renewal of an application to study the impact of hospitalists on the care of older hospitalized patients. We have used 5% national Medicare data to describe the growth of hospitalists from 1996 through 2006 to evaluate the association of care by hospitalists with length of stay;to assess how the impact of hospitalists on length of stay varies by patient and hospital characteristics, and disease severity;to examine how hospitalist care effects continuity of care during hospitalization and across the transition from community to hospital and back;to describe the growing role of hospitalists in caring for surgical patients;and to begin to describe the outcomes of hospitalist care. We have found evidence of cost shifting;that is, hospitalist care is associated with reduced hospital length of stay and costs but increased Medicare expenditures post discharge. Our Specific Aims are: 1. Examine the association of care by hospitalists with processes and outcomes of care, focusing on quality indicators at the hospital level. Is adoption of a hospitalist model by a hospital accompanied by improvements in quality? 2. Examine the impact of adoption of an electronic medical record (EMR) system on hospitalist care. Does implementation of a complete EMR impact the relative advantage of hospitalists on length of stay? Does implementation of an EMR in a hospital system reduce or eliminate the association of hospitalist care with increased utilization and costs post discharge? 3. Explore the use of 100% Medicare data to assess performance of individual hospitalists. We will address these aims using the 5% national sample of Medicare charge data from 1995 through 2010, and 100% Medicare data from Texas for 2000-2010. PUBLIC HEALTH RELEVANCE: Over the past 10 years patients hospitalized for medical illnesses are increasingly more likely to be cared for by full-time hospital physicians, termed hospitalists. We propose to study how care by hospitalists affects overall quality of care in a hospital. We also will use 100% Medicare data to describe variation among hospitalists in their performance;for example, in the percent of their patients who are readmitted to the hospital after discharge.

Public health relevance
Over the past 10 years patients hospitalized for medical illnesses are increasingly more likely to be cared for by full-time hospital physicians, termed hospitalists. We propose to study how care by hospitalists affects overall quality of care in a hospital. We also will use 100% Medicare data to describe variation among hospitalists in their performance; for example, in the percent of their patients who are readmitted to the hospital after discharge.